Dendrite regulation by the mitochondrial kinase PINK1: Implications for PD/LBD

Dendrite regulation by the mitochondrial kinase PINK1: Implications for PD/LBD
PROJECT SUMMARY.
Synaptic loss is a major structural correlate of dementia, and reduced spine density is observed in
Alzheimer’s disease (AD) and the Lewy body dementia (LBD) disease spectrum. Autosomal recessive
mutations in PTEN-induced kinase 1 (PINK1) cause early-onset Parkinson’s disease (PD) and PD with
dementia (PDD), with heterozygous carriers exhibiting cognitive-executive dysfunction and cortical
degeneration in the absence of motor symptoms. Given that wild type PINK1 is reduced in the cortex of
patients with sporadic PDD and AD, we studied the role of endogenous PINK1 in regulating dendritic
branching, spine density and function in the previous project period. We elucidated a novel signaling
pathway by which PINK1 promotes dendritic arborization, discovered that Pink1-/- neurons exhibit reduced
dendritic spine density in vitro and in vivo, and identified a novel PINK1-regulated motor protein
phosphorylation site. In the current proposal, we will test the hypothesis that alterations in dendritic
mitochondrial transport in PINK1-deficient neurons result in defective mitochondrial support of
synaptic plasticity. We will employ molecular genetic manipulations, glutamate uncaging and
electrophysiology to study the impact of PINK1 loss-of-function on dendritic transport of mitochondria,
mitochondrial motor proteins, and perisynaptic mitochondrial positioning in Pink1-/- mouse neurons and
PINK1-mutated patient iPSC-derived cortical neurons. We will also study the impact of PINK1 deficiency on
spine dynamics and cognitive function in Pink1-/- mice in vivo. A better understanding of novel PINK1-
driven mechanisms that promote dendritic health and spine function may yield valuable insights relevant to
neuroprotection for these devastating neurodegenerative diseases.

Public health relevance
PUBLIC HEALTH NARRATIVE. Loss-of-function mutations in PTEN-induced kinase 1 (PINK1) contribute to a recessive form of Parkinson's disease with early cognitive dysfunction. In the prior grant period, we discovered that loss of PINK1 results in diminished numbers of dendritic spines, particularly the type of spine most closely associated with long- term memory storage. We will determine whether mitochondrial transport into dendrites is impaired by loss of PINK1, and how PINK1 activity regulates brain cell responses involved in learning and memory in cultured mouse and human neurons. These studies will help identify new strategies to prevent or slow the loss of brain cell function in Parkinson's disease and related neurodegenerative dementias.